Characterization of ENTPD1 as a drug target in PXE

This research will focus on pseudoxanthoma elasticum (PXE), the prototype of heritable ectopic mineralization
disorders. Aberrant calcium phosphate deposition in PXE results in characteristic cutaneous findings which
signify the potential for development of ocular complications leading to loss of visual acuity and blindness, as
well as cardiovascular involvement, including nephrogenic hypertension, intermittent claudication, bleeding from
gastrointestinal arteries, early myocardial infarct and stroke. There is no effective treatment for PXE and the
disease therefore progresses after diagnosis. PXE is caused by mutations in the ABCC6 gene which encodes
ABCC6, an efflux transporter expressed primarily in the liver. Our group elucidated the pathophysiology
underlying PXE, by showing that ABCC6 in hepatocytes mediates release of ATP into the blood circulation.
Released ATP is extracellularly converted by the ecto-nucleotidase ENPP1 into 1 molecule of AMP and 1
molecule of the potent mineralization inhibitor inorganic pyrophosphate (PPi). PXE patients bearing defective
ABCC6 have low PPi plasma concentrations, explaining their progressive calcification of soft connective tissues.
Plasma PPi homeostasis is maintained through a complex network of proteins involved in ATP release, and
ecto-nucleotidases metabolizing the released nucleotides. ENPP1 is crucial in this respect, as its activity
underlies all PPi present in plasma. The ~40% of residual PPi present in plasma of PXE patients is formed out
of ATP released by cells independent of ABCC6. Extracellular ATP is also subject to metabolism by other ecto-
nucleotidases and the most important competitor of ENPP1 in the circulation is ENTPD1, which converts ATP
into 1 molecule of AMP and 2 molecules of inorganic phosphate. Importantly, ENPP1 and ENTPD1 have
opposing effects on extracellular PPi homeostasis and, consequently, ectopic calcification. In this study we
propose to test the hypothesis that inhibition of ENTPD1 enhances extracellular PPi formation and
prevents ectopic calcification in PXE patients We have developed two Specific Aims to test our hypothesis:
(1) Thoroughly characterize how competition between ENPP1 and ENTPD1 affects extracellular PPi
homeostasis in vitro and (2) Determine the effect of ENTPD1 on plasma PPi concentrations and ectopic
calcification in Abcc6-/- mice in vivo. These plans are based on solid preliminary data, and they take advantage
of a well-characterized mouse model developed and characterized in our department – the Abcc6-/- mouse –,
which recapitulates the clinical, histopathologic, ultrastructural and genetic features of PXE in humans.
Collectively, our state-of-the-art studies utilizing both in vitro and in vivo model systems are expected to provide
critical preclinical information of the therapeutic potential of ENTPD1 inhibition to restore plasma PPi levels in
PXE, with subsequent inhibition of ectopic calcification. Our findings are expected to not only inform development
of pharmacologic treatments for PXE, but also for other ectopic calcification disorders, for which no effective or
specific therapy is currently available.

Public health relevance
Project Narrative The clinical manifestations encountered in patients suffering from the hereditary ectopic calcification disorder pseudoxanthoma elasticum (PXE) are caused by insufficient formation of the mineralization inhibitor inorganic pyrophosphate (PPi) in plasma. Cellular release of ATP and subsequent conversion by the ecto-nucleotidase ENPP1 underlies all PPi present in plasma. We propose to explore if inhibition of ENTPD1, an ecto- nucleotidase that competes with ENPP1 for available ATP in the extracellular space but forms inorganic phosphate (Pi) instead of PPi, enhances PPi formation in the circulation and inhibits ectopic calcification in Abcc6-/- mice, an extensively validated animal model for PXE.